Genetic Contributors to White Matter Microstructure in Aging and Alzheimers Disease

PROJECT SUMMARY
While reductions in medial temporal lobe (MTL) white matter tract microstructure have been suggested to have
a central role in longitudinal cognitive decline in aging and Alzheimer’s disease (AD), it is unknown what
genetic factors drive these reductions. The objective of this proposal is to use MTL white matter tract templates
in conjunction with genome-wide analyses to identify the genetic drivers of white matter tract microstructure.
This proposal will leverage several aging datasets, including the Alzheimer’s Disease Neuroimaging Initiative
(n=525), Baltimore Longitudinal Study of Aging (n=295), Religious Orders Study/Memory and Aging
Project/Minority Aging Research Study (n=414), Vanderbilt Memory & Aging Project (n=319), Wisconsin
Alzheimer’s Disease Research Center (n=488), and Wisconsin Registry for Alzheimer’s Prevention (n=468) to
conduct all analyses, totaling in 2,509 participants. Moreover, validation of all results will be conducted using
data from a well-established lifespan study (UK Biobank (n=14,701)) and data from the AD Genetics
Consortium. The central hypothesis is that MTL white matter tract microstructure is driven by genes and
pathways related to myelination, axonal transport, and neuroinflammation in aging and AD. Based on this
hypothesis, the primary aims of this proposal will take a multi-level approach to understand which genes and
pathways lead to MTL white matter microstructure by using: (1) a candidate gene approach to determine with
AD-risk genes are associated with MTL white matter microstructure, (2) a genome-wide approach to identify
novel variants which contribute to MTL white matter microstructure and quantify genetic overlap with other
traits, and (3) a genome-wide approach to identify how gene expression is associated with MTL white matter
tract microstructure and localize signals to relevant biologic pathways. The complementary training plan will
equip me with the skills necessary to transition to an independent career focused on imaging genetics by
emphasizing the following training objectives: (a) expand expertise in computational genetics, (b) acquire a
practical understanding of the pathophysiology and clinical manifestation of AD, and (c) enhance my skillset in
data harmonization and big data analytical techniques. The mentoring team is made up of experts in each of
these areas, and their training will be augmented through formal coursework, interdisciplinary training at the
Vanderbilt Memory & Alzheimer’s Center, and cutting-edge computational and genomic resources available at
the Vanderbilt University Medical Center. Together, these practical and intellectual resources provide the ideal
training environment, and my primary mentor, Dr. Timothy Hohman, has a well-funded laboratory which will
provide all the necessary resources for career transition. These resources will allow me to dedicate 100%
protected effort as an Assistant Professor to focus on research and career development. This will ensure that I
can competitively compete for independent funding (R01) over the course of the proposed award period.

Public health relevance
PROJECT NARRATIVE Reductions in white matter microstructure have been implicated as a central feature of Alzheimer’s disease (AD); yet, the molecular drivers of white matter alterations are unknown. The goal of this project is to perform rigorous evaluation of the genetic and molecular pathways of medial temporal lobe white matter microstructure that contributes to accelerated cognitive decline in AD. Such work will serve as a catalyst for the identification of novel therapeutic targets for neurodegenerative disease.